The Impact of SARS-CoV-2 Immune Dysregulation on Antifungal Immunity

Project Summary
Despite hundreds of published articles, meta-analyses, and reviews describing the clinical syndrome of
COVID-Associated Pulmonary Aspergillosis (CAPA), there have been zero publications to date exploring the
mechanism by which individuals with severe SARS-2 infection succumb to 2° mold infection. This proposal
seeks to evaluate the novel conceptual advancement that immune responses targeting intracellular
viral pathogens, like SARS-2, promote 2° mold infection via release of bioavailable iron, delayed
neutrophil (PMN) recruitment, and decreased antifungal effector (αFE) expression. In Aims 1-3, we
explore the hypotheses that lytic programmed cell death (PCD) in pulmonary epithelial cells (PEC) and red
blood cell hemolysis increase the availability of nutrients including iron/heme which drive siderophore-
dependent acceleration in mold growth. Concurrently, SARS-2 and the antiviral cytokine milieu mitigate PMN
recruitment and activation resulting in spore germination into large invasive hyphae that overwhelm αFE
mechanisms enabling 2° mold infection in an otherwise immunocompetent host. In Aim1, we will quantify iron,
heme, divalent cations, host metal sequestration proteins (MSP), antiviral cytokines, and PMN-recruiting
chemokines in SARS-2 BALs vs control infection cohorts (IC). We will also use immunofluorescence (IF) and
spatial transcriptomics to characterize lytic PCD, viral ORF3a-mediated cell lysis, and αFE expression in FFPE
lung tissues and utilize isogenic mutant fungi to identify critical host and microbial factors mediating mold
growth in BALs. In Aim2, we will utilize novel Calu-3 knockout (KO) cell lines and 1°normal human bronchiole
epithelial (NHBE) air liquid interface cell cultures to study the impact of the lower airway milieu and direct
SARS-2 infection on PEC: lytic PCD, IFN synthesis, αFE secretion, metal sequestration, and ability to respond
to 2° fungal stimuli. We will also utilize isogenic mutant fungi to identify critical pathways mediating mold growth
and an innovative PMN airway transmigration model to determine the impact of Type I and III IFNs, iron/heme
toxicity, and SARS-2 uptake on PMN recruitment, activation, and fungal killing. In Aim3, we will utilize novel
conditional KO mice, fluorescent viral and fungal reporter strains, IF, flow cytometry, and single cell sequencing
to assess the potential of SARS-2 variants to induce lytic PCD, define the role of lytic PCD and IFN signaling
in PECs, macrophages (Mφ), and PMNs, and evaluate their impact on lung pathology, metal release, PMN-
recruitment, spore viability, fungal growth, and infection outcome. We will also dissect key host MSP and fungal
pathways mediating mold growth, evaluate the role of Mφ and PMN hACE2 on viral and fungal clearance and
determine if small molecule inhibitors of lytic PCD, iron chelators, and siderophore biosynthesis inhibitors
prevent or mitigate the development of 2° mold infection. We believe that the results of the proposed study
will shed new light on the fundamental biology mediating CAPA and may enable the development of improved
therapeutic regimens that mitigate the risk of acquiring and succumbing to this devastating infection.

Public health relevance
Project Narrative The proposed study focuses on understanding the mechanism/s mediating COVID Associated Pulmonary Aspergillosis (CAPA). Based on strong preliminary evidence and utilizing unique access to well-curated patient samples as well as innovative in vitro, ex vivo, and in vivo model systems we explore the novel hypotheses that lytic programmed cell death in pulmonary epithelial cells and red blood cell hemolysis increase the availability of nutrients including iron/heme, which drive siderophore-dependent acceleration in mold growth. Concurrently, SARS-2 and the antiviral cytokine milieu mitigate PMN recruitment and antifungal effector activation resulting in spore germination into large invasive hyphae that overwhelm antifungal immunity enabling 2° mold infection in an otherwise immunocompetent host. We believe that the results of the proposed study will shed new light on the fundamental biology mediating CAPA and may enable the development of improved therapeutic regimens that mitigate the risk of acquiring and succumbing to this devastating infection.